Characterizing complex structural variation in Alzheimer's disease

PROJECT SUMMARY
Late-onset Alzheimer’s disease (LOAD) is genetically complex and thought to be associated with variants in a
number of different loci, including structural variants (SVs), which could in part explain the additional missing
heritability and genetic background. However, the impact of SVs on LOAD has not been systematically explored,
while findings regarding CNV associations with AD risk have been overall inconsistent. To address this gap in
knowledge, we propose to fully characterize the genetic architecture of SVs in LOAD by leveraging previously
generated large-scale whole genome sequencing data. To this end, we will systematically characterize SVs
across 39,000 samples from multi-ethnic, well-phenotyped individuals sequenced as a part of Alzheimer’s
Disease Sequencing Project (ADSP) discovery, extension replication (ADSP-DEP) and follow-up datasets
(ADSP-FUS), as well as in over 1000 multiplex families. Identification of novel SVs associated with LOAD could
implicate previously unknown genes and elucidate biological mechanisms that could be leveraged to generate
novel therapeutics and diagnostic markers.

Public health relevance
PROJECT NARRATIVE Structural Variants (SVs) could contribute to some of the missing heritability of Late-Onset Alzheimer’s Disease (LOAD). However, SVs have been not been accurately and thoroughly characterized in sequencing studies due to challenges in detection and validation of structural rearrangements. To address this gap in knowledge, we propose to comprehensively characterize SVs in LOAD using whole-genome sequencing data generated as part of the Alzheimer’s Disease Sequencing Project (ADSP), as well as additional long-read sequencing available through collaborators, which could identify novel locus disease relationships leading to putatively novel therapies.